Development of an MRI Template & Neuroimaging Biomarkers of the Pediatric Spinal Cord

The neurological consequence of spinal cord injury (SCI) in children is not fully understood. The inability to
accurately assess motor, sensation and extent of injury in the pediatric population raises speculation about
diagnoses, recovery potential, and treatment effectiveness. This proposed study builds upon the team's
previous work to establish quantitative imaging biomarkers using advanced imaging methods such as diffusion
tensor imaging (DTI), diffusion kurtosis imaging (DKI) and atrophy estimated through a spinal cord cross
sectional area (SCCSA) – in pediatric SCI patients. In the recent years magnetic resonance imaging (MRI)
methods such as DTI, DKI, SCCSA measurements, and Neurite Orientation Density Dispersion Imaging
(NODDI) have shown promising results as powerful and non-invasive biomarkers to evaluate the spinal cord
(SC) in children. To the best of our knowledge, our research team is the only one thus far to apply these
imaging techniques to the pediatric population. Although all of these techniques have demonstrated potential
for providing microstructural information about the SC, the development and application of objective diffusion-
based biomarkers for identifying the precise location of the injured cord has been challenging because neither
a standard anatomical template of the pediatric SC nor biological age and sex matched normative values are
available. Hence, the first aim of this study is to create a standardized SC imaging template and establish
SCCSA measurements of the entire pediatric SC between 6-17 years of age. The second aim of this study will
establish normative multishell diffusion imaging values for continuous segments of the cervical-thoracic
pediatric SC between 6-17 years of age. This work will result in standardization and consistent interpretation of
these neuroimaging metrics and will reduce user variability. A sub aim of this work is to demonstrate the
feasibility of these imaging biomarkers in a group of children with chronic motor complete (American Spinal
Injury Association Impairment Scale (AIS) A and B) SCI. This work will address a significant knowledge gap by
providing functional imaging biomarkers to clinicians and researchers so they can objectively determine the
extent of severity and level of injury and develop prediction models in pediatric SCI. This work would also aid
clinicians in assessing neurological recovery, and evaluate treatment effectiveness in clinical trials. In addition,
these imaging biomarkers and normative templates can be extended to other pediatric SC diseases in the
future.

Public health relevance
Relevance to Public Health: The current clinical method to evaluate and classify neurological impairment of spinal cord injury (International Standards for Neurological Classification of Spinal Cord Injury (ISNCSCI)), causes anxiety in children up to eight years of age, is difficult to administer (invasive), and does not provide a direct assessment of damage to white matter tracts within the spinal cord. The creation of the first pediatric spinal cord structural template, which will be made available to the scientific community, will allow for examination of the spinal cord in a standardized space for group studies and can remove user variability during the analysis process. Also, if functional imaging measures such as DTI, DKI, NODDI, and SCCSA can be established as valid and reliable methods to quantify viable neural tissue within the spinal cord in young children, it will be a critical non invasive neurodiagnostic tool and a useful adjunct to the current ISNCSCI (The Standards).